GLUTATHIONE CYSTEINE INTERRELATIONSHIPS IN VIVO

Using stable isotope tracers to explore the hypothesis that under conditions of physiologic and pathologic stress, an exogenous precursor source, preferably of cystine, is needed to effectively maintain GSH homeostasis.